Design and characterization of biomimetic nanobiomaterials to elicit CD1-restricted T cell responses during sub-unit vaccination

PROJECT SUMMARY
Subunit vaccines combine immunodominant protein or peptide antigens from pathogens with select
adjuvants, aiming to provide a more scalable, reproducible, low cost and rapid alternative to attenuated vaccines
that contain live pathogens. Unfortunately, current subunit vaccines lack lipid antigens and rarely achieve the
broad T cell responses required for lasting immunological memory and protection. In contrast, attenuated
vaccines lack customization and scalability, but incorporate the entire pathogen to provide both protein and lipid
antigens during immunization. This combination of lipid and protein antigens activates a broad spectrum of
effector T cells, including conventional MHC-restricted T cells that respond to peptides and display considerable
polymorphism, as well as nonpolymorphic CD1-restricted T cells that are directed against specific lipids. A more
biomimetic strategy that simultaneously activates both lipid- and peptide-specific T cells may therefore show
enhanced efficacy and control compared to subunit vaccines limited to protein antigens.
The neglect of lipid antigens from current subunit vaccines and immunotherapies is primarily due to 1)
difficulties in targeted delivery of lipids, and 2) a lack of suitable mouse models. In humans, the CD1 family
consists of group 1 CD1 molecules (CD1a, CD1b, and CD1c) and the group 2 CD1 molecule CD1d. Mice,
however, only express CD1d. This project, which involves a close collaboration between research groups led by
a bioengineer and a basic immunologist, aims to overcome these obstacles by designing nanobiomaterials for
enhanced dual delivery of both lipid and protein antigens in combination with adjuvants to induce CD1- and
MHC- restricted T cell response in humanized CD1 transgenic (hCD1Tg) mice. To characterize, optimize and
benchmark these novel nanobiomaterials against the most frequently used attenuated vaccine in the world, the
bacillus Calmette-Guérin (BCG) tuberculosis (TB) vaccine, the following aims are proposed: In Aim 1, in vitro
and in vivo approaches will identify the optimal nanobiomaterials and adjuvant combination for eliciting a
combined CD1- and MHC-restricted T cell response. In Aim 2, a lipid/protein multi-antigen approach will be
validated in hCD1Tg mice challenged with virulent Mycobacterium tuberculosis (Mtb). In Aim 3, a novel hydrogel
delivery system will be employed for controlled and sustained release of lipid-antigen-loaded nanobiomaterials
to assess efficacy and safety of chronic CD1-restricted T cell activation. The proposed study will provide a “proof
of concept” that combining Mtb lipids and proteins into a single subunit vaccine formulation that targets both
conventional and unconventional T cell subsets can enhance overall immunity to Mtb infection. The methodology
and antigen/adjuvant delivery systems developed in this study will guide the next generation of multi-subunit
vaccines for TB and other bacterial pathogens to provide scalable routes of rapid vaccine fabrication.

Public health relevance
PROJECT NARRATIVE Live attenuated bacterial vaccines elicit broad immune responses against both lipid and protein components, yet current subunit vaccine strategies do not sufficiently incorporate the lipid-specific mechanisms of immunity. We propose the in vitro and in vivo optimization and characterization of a versatile nanobiomaterial-based vaccine delivery system designed for simultaneous elicitation of both lipid- and peptide-specific immune responses. Engineered nanobiomaterials, novel sustained release hydrogels, and rationally selected antigen and adjuvant combinations will be evaluated for toxicity and efficacy in unique humanized mouse models challenged with virulent Mycobacterium tuberculosis.